Administrative Supplements for the NCI P30 Cancer Center Support Grants for Multi-Channel Communication Campaigns for Improvements in Cancer Education and Outcomes (MICEO) in Underserved Populations

Project Summary
The goal of our project is to address common misperceptions about cancer prevention, increase rates of
cancer screenings (e.g. breast, cervical, colorectal, lung) and tobacco use intervention among otherwise
medically underserved adults age 30+ (Track 2). This project builds on our ongoing collaboration with the
Michigan Primary Care Association (our state FQHC network) and Packard Health (our local FQHC). Over the
past three years, we have worked together on the UM Rogel Cancer Center supported Catch Up on Cancer
Screening initiative to address the impact of COVID-19 pandemic on cancer screening. While we have had
initial success in these efforts, we have also identified critical needs to increase the effectiveness of population
health outreach, leverage and magnify the contributions of community health educators (CHEs), and identify
optimal strategies for patient engagement.
We propose to address these critical needs by 1) Developing a community-engaged personally tailored cancer
screening and prevention digital planning tool (CanPlan), 2) Promote CanPlan engagement through multi-
channel outreach (Direct-to-patient messaging, Proactive CHE outreach, Health center focused social
marketing, Local community focused social media, Peer-to-peer snowball recruitment). The tailored CanPlan
program will engage users to create a personally tailored cancer prevention action plan. Innovative features of
the CanPlan program include 1) Speaking in the voice of CHEs (through tailored video), 2) Incorporation of
local community and crowdsourced cancer screening and prevention messages, and 3) Recognizing and
responding to user reported everyday experience of discrimination, medical mistrust, and unmet social
determinants of health (SDOH) needs.
We will evaluate CanPlan implementation (e.g. engagement, engagement efficiency, user characteristics), and
patient-reported (understanding of cancer prevention key facts, behavioral activation, program satisfaction),
and utilization (e.g. cancer screening) outcomes. Evaluation will address CanPlan performance overall and
separately for each outreach channel. Upon completion of the proposed work, we will be in a strong position to
disseminate the CanPlan program and guide CanPlan promotion with stakeholders throughout the state and
potentially across the country.

Public health relevance
Project Narrative The University of Michigan Rogel Cancer Center and Packard Health (local Federally Qualified Health Center, or FQHC) will partner to develop a community-engaged personally tailored cancer screening and prevention digital planning tool (CanPlan) to address common misconceptions about cancer prevention and increase rates of cancer screening (e.g. breast, cervical, colorectal, lung) and tobacco use intervention among adults age 30+ who are patients at Packard Health or live in Packard Health’s service area. We will promote and evaluate CanPlan engagement and outcomes through multi-channel outreach (Direct-to-patient messaging, proactive CHE outreach, health center focused social marketing, local community focused social media, peer-to-peer snowball recruitment by CanPlan users). The innovative CanPlan program will engage individuals in the creation of a personalized cancer screening and prevention action plan while 1) Speaking in the voice of CHEs (tailored video), 2) Sharing community and crowdsourced screening and prevention messages, and recognizing and responding to 3) Everyday experience of discrimination, 4) Medical mistrust, and 5) Unmet SDOH needs.